Targeting Nucleotide Excision Repair Deficiency to Improve Bladder Sparing Treatment for Muscle Invasive Bladder Cancer

PROJECT SUMMARY
Organ-preserving therapy is the standard curative approach for numerous types of solid tumors. For patients
with muscle-invasive bladder cancer (MIBC), bladder removal (radical cystectomy) and bladder-preserving
chemoradiotherapy (CRT) are the two curative treatment approaches supported by long-term safety and efficacy
data; however, these two approaches have never been compared in a randomized trial. Therefore, the decision
between approaches is currently made based solely on clinical-pathologic features and patient/provider
preference. There are currently no molecular biomarkers available to inform the decision between radical
cystectomy and bladder-sparing CRT. Our previous work identified a subset of ~15% of MIBCs with somatic
alterations in the nucleotide excision repair (NER) gene ERCC2. The NER pathway is a highly conserved DNA
repair pathway that repairs bulky DNA adducts caused by genotoxins such as UV irradiation and platinum drugs.
We showed that MIBC patients with ERCC2-mutant tumors have improved response to cisplatin-based
chemotherapy compared to MIBC patients with wild-type (WT) ERCC2 tumors, and our functional work
demonstrated that clinically observed ERCC2 mutations were unable to support normal cellular NER and were
sufficient to confer increased cisplatin sensitivity in preclinical bladder cancer models. However, the impact of
ERCC2 mutations on response to clinical CRT regimens is unknown. The overarching hypothesis of this proposal
is that NER deficiency conferred by ERCC2 mutations define a subset of bladder tumors with unique biological
properties and therapeutic vulnerabilities, including increased sensitivity to clinically relevant CRT regimens. The
goal of work proposed here is to dissect the cellular mechanisms that contribute to the unique properties of NER
deficient tumors and to define the impact of NER deficiency on CRT response. In Aim 1, we will investigate the
association between mutations in ERCC2 and other NER pathway genes and clinical outcomes in a cohort of
240 MIBC patients treated with CRT on completed cooperative group trials. We will functionally interrogate the
impact of observed NER gene alterations in bladder cancer models and we will compare the activity of commonly
used CRT regimens in isogenic NER-proficient/deficient human bladder cancer preclinical models. In Aim 2, we
will define the impact of NER deficiency on immune cell subsets in the bladder tumor microenvironment in two
isogenic NER-proficient/deficient mouse bladder cancer models and we will investigate the contribution of CD8+
T cells to CRT response in the NER-proficient and NER-deficient models. We will also perform transcriptional
profiling of 190 clinical MIBC cases and will investigate the relationship among ERCC2 mutation status,
transcriptional signatures of immune infiltration, and clinical outcomes. In Aim 3, we will investigate CHK1
inhibition as a strategy to induce NER deficiency and increase sensitivity to cisplatin-based treatments in bladder
tumors with WT ERCC2. Together, these integrated genomic and functional studies will define the impact of
NER deficiency as a biomarker and therapeutic target in bladder-sparing treatment approaches for MIBC.

Public health relevance
PROJECT NARRATIVE Bladder removal surgery (radical cystectomy) and bladder-sparing chemoradiotherapy (CRT) are the two curative treatment approaches for muscle-invasive bladder cancer supported by long-term safety and efficacy data, but no molecular biomarkers are currently available to inform the choice between these approaches. We have identified a subset of ~15% of MIBCs with somatic alterations in the nucleotide excision repair (NER) gene ERCC2, and we have shown that clinically observed ERCC2 mutations are unable to perform cellular NER and are sufficient to confer cisplatin sensitivity in MIBC preclinical models. We will define the impact of NER deficiency induced by ERCC2 mutations on bladder tumor properties and on response to clinically relevant bladder-sparing CRT regimens by integrating genomic and clinical data from clinical MIBC cohorts with functional data from novel NER-proficient and NER-deficient preclinical models.